Dissecting the Functional Role of PAX5 Mutations in B-cell Acute Lymphoblastic Leukemia

PROJECT SUMMARY
B-cell acute lymphoblastic leukemia (B-ALL) is the most common pediatric cancer and remains a leading cause
of childhood cancer death. Over 10% of B-ALL cases have point mutations in PAX5, a gene that encodes a key
transcription factor for B-cell development. PAX5 mutations are the signature lesions in two recently identified
B-ALL subtypes: PAX5alt, characterized by diverse genetic alterations in PAX5, and a subtype defined by PAX5
P80R mutation. While PAX5alt patients, particularly adults, have a significantly worse prognosis compared to
PAX5 P80R patients, the underlying mechanisms driving these differences remain poorly understood. Both
subtypes frequently acquire additional genetic alterations, such as wild-type PAX5 allele deletion and Ras
pathway mutations, which further contribute to disease progression. Despite advances in chemotherapy, many
patients experience suboptimal outcomes and poor quality of life, emphasizing the need for improved therapies.
Our preliminary studies show that PAX5 P80R leukemic cells have increased sensitivity to Dexamethasone (Dex)
treatment, likely due to high dependence on glucose uptake and glycolytic activity. These findings suggest that
metabolic alterations contribute to the differential clinical responses observed between the two PAX5-driven
subtypes. To systematically dissect these mechanisms, we will use orthogonal experimental models (e.g., B-
ALL cell lines, mouse leukemia models, and human B-ALL samples) alongside multi-omics platforms, such as
RNA-seq, CUT&Tag, ATAC-seq, END-seq, whole-genome sequencing, and single-cell analyses in this project.
We hypothesize that rather than loss of function, PAX5 mutants can exert dominant effects in B-ALL initiation
through novel PAX5 binding activities and gene transcription activation, which may block normal B-cell
differentiation and give rise to pre-leukemic cells; once additional genetic lesions are acquired, PAX5-mutant
clones can progress to overt B-ALL. We aim to (Aim 1) identify the transcriptional and metabolic alterations
induced by PAX5 mutants, particularly their different effects on Dex treatment. Additionally, we will (Aim 2)
investigate the stepwise acquisition of genetic lesions that drive leukemic transformation, with a focus on the
pre-leukemic cells and their transition to overt leukemia using the Pax5 P80R mouse model. Finally, we will (Aim
3) study the role of aMEGF10, a gene significantly overexpressed in PAX5 P80R B-ALL, and assess the
therapeutic potential of targeting the novel aMEGF10-SYK signaling pathway.
In summary, this project will provide comprehensive insights into the molecular features of PAX5-mutant B-ALL
subtypes, reveal novel mechanisms of leukemogenesis and treatment responses, and identify potential
therapeutic targets. These findings are expected to improve patient risk-stratification and lead to the development
of more effective targeted therapies with lower toxicity for PAX5-mutant B-ALL.

Public health relevance
Project Narrative Over 10% of B-cell acute lymphoblastic leukemia (B-ALL), the most common childhood cancer, are driven by mutations in the PAX5 gene. These mutations define two distinct subtypes of B-ALL, which have different responses to clinical treatment. Our project will use advanced experimental models and analytical approaches to study how PAX5 mutations affect leukemia development and treatment responses, with the goal of developing and optimizing targeted therapies that improve long-term survival while reducing treatment-related toxicity for these patients.